Cardiovascular and respiratory responses to physical activity and heat stress in burn survivors

PROJECT SUMMARY/ABSTRACT
Despite being healed from their burn injuries, burn survivors have impaired thermoregulation, decreased
pulmonary function with accompanying dyspnea at rest and during exercise, a greater incidence of
cardiovascular disease, and higher mortality rates. Regarding the former, grafted skin does not appropriately
dissipate heat, resulting in exaggerated increases in core temperature during physical activity in this population.
Skin wetting of just the grafted sites blunts the exaggerated increases in core temperature, and perhaps the
accompanying increased cardiac and pulmonary stress, though the latter has not been experimentally verified.
Therefore, we aim to investigate the efficacy of whole-body skin wetting to mitigate otherwise heightened
indices of cardiac and pulmonary stress during physical activity in the heat in well-healed burn
survivors. As a secondary exploratory aim to continue to explore the consequences of a severe burn injury on
long term health, we aim to investigate the possible effects of an inhalation injury, time on a ventilator,
and/or significant torso burns and associated skin scarring on detailed respiratory function and
mechanics at rest and during physical activity in well-healed burn survivors. The overarching goal of the
proposed work is to identify physiological barriers, and assess a potential mitigation strategy, that likely dissuade
burn survivors from achieving the recommended levels of physical activity necessary for their cardio-metabolic
health, thereby predisposing burn survivors to the aforementioned greater mortality risk. The expected
outcomes from this work will have a direct impact on burn survivors and their caretakers by evaluating the
efficacy of a practical cooling strategy that has the potential to decrease cardiac stress and reduce the severity
of dyspnea thereby improving exercise “comfortability” in burn survivors. Secondly, establishing a foundation of
the effects of a severe burn injury on detailed respiratory mechanics is necessary to develop future studies where
interventions (i.e., inspiratory muscle training) can be tested to improve the mechanics of breathing in this
population. This research directly supports the mission of the NIH in that we will uncover mechanistic
physiological findings from human participants with the goal of translating those findings to guide individuals and
caregivers on how to increase exercise tolerance in burn survivors thereby improving their quality of life. To
ensure that this study is designed to maximize clinical relevance and my scientific training, I assembled a strong
interdisciplinary clinical research/mentoring team consisting of expert integrative physiologists, physician-
scientists, and a biostatistician. My primary goals during this fellowship are to complete the proposed project,
master several technical skills (i.e., echocardiography), improve my ability to obtain future extramural research
funding, and publish research findings in peer-reviewed medical and physiology journals.

Public health relevance
PROJECT NARRATIVE This project addresses two unique, yet interconnected, objectives: 1) assess the extent to which a cooling modality (whole-body skin wetting) alleviates excessive cardiopulmonary stress in burn survivors during physical activity; and 2) characterize the effects of respiratory complications associated with a severe burn injury (i.e., thoracic burn scars, inhalation injury, and time spent on a ventilator) on respiratory mechanics at rest and during exercise. Both objectives will lead to improved physical activity adherence that will benefit the cardio-metabolic health of this at-risk population.